Mechanoregulation of E-cadherin Adhesion

Project Summary
E-cadherin is the primary mediator of strong cell-cell adhesion between epithelial cells and plays an
essential role in the morphogenesis and maintenance of epithelial tissues. E-cadherin is also a known
mechanosensor that actively responds to the levels of inter-cellular forces and resides in a
microenvironment formed by adjoining epithelial cells. The long-term goal of the project is to understand
how the mechanical regulation of E-cadherin adhesion leads to a cohesive yet dynamic multi-cellular
architecture in epithelial tissues. The goal of the proposed project is to delineate the mechanism by which
forces are transmitted via E-cadherin adhesions and to uncover how epithelial cells sense cell-like stiffness
laterally via E-cadherin adhesions. The E-cadherin-β-catenin-α-catenin complex directly and indirectly
couples to actin to transmit cell-generated forces. Firstly, while the α-catenin-vinculin link, which plays a role
in force sensing is thought to be the primary force transmission pathway, we recently found that,
surprisingly, α-catenin is not essential for force transmission. Therefore, we will test the hypothesis that the
less studied β-catenin-vinculin link is an alternate significant mechanism of force transmission at E-cadherin
adhesions. We will test this by using mutant versions of vinculin and α-catenin deficient in binding β-catenin
and vinculin, respectively, and corresponding knockout cell lines. We will use traction force microscopy with
E-cadherin-coated soft substrates to avoid the confounding factor of vinculin’s mechanical role in cell-matrix
contacts. We will also use magnetic pulling cytometry with E-cadherin-coated beads and biaxial stretching
of cell islands to assess the adhesion strength at multiple scales. Secondly, while E-cadherin has been
shown to sense the stiffness of E-cadherin-coated soft substrates, it is still unclear if epithelial cells sense
cell-like stiffness laterally via E-cadherin adhesions. To test this, we will devise a biomimetic model of E-
cadherin in a physiologically relevant geometry, in which cells interface laterally with an E-cadherin-coated,
stiffness tunable, soft surface. We will test the hypothesis that lateral sensing of cell-like stiffness modulates
E-cadherin density, cell dynamics, Rho and YAP levels. We will also test whether this lateral stiffness
sensing is dependent on the α-catenin-vinculin mechanotransduction axis. We will use biomimetic soft
substrate fabrication, mutant version of α-catenin deficient in binding vinculin in α-catenin knockout cells,
sensors/indicators of Rho and YAP, and perform live-cell imaging and immunofluorescence to accomplish
this. Knowledge gained on cell-to-cell force transmission and epithelial cell sensing of neighboring cell
mechanical properties will be crucial in understanding the context-dependent biophysical control of E-
cadherin adhesion. This will be essential to better understand the functional basis of the role of E-cadherin
in mediating epithelial tissue integrity, mechanical coherence and its dysregulation in disease states like
cancer.

Public health relevance
Project Narrative The proposed project determines how adhesions that help cells stick to one another in solid tissues transmit forces from cell to cell as well as how these adhesions may be affected by the mechanical properties of cells around the adhesions. Attainment of the aims proposed in the project will enable a better understanding of key events in development as well as what disrupts tissue organization in diseases like cancer.